SPINAL CORD PLASTICITY: BEHAVIORAL AND NEURAL MECHANISMS

Traditionally, the spinal cord was viewed as a conduit between the brain and the periphery, organizing some simple reflexes, but otherwise contributing little to learning and behavior. However, recent studies suggest that a great deal of information processing occurs within the spinal cord, and that this system not only tunes the afferent and efferent input/output at the brain's bidding but also adapts on its own to new environmental relations. Learning within the spinal cord can be studied using rats that have undergone a spinal transection at the second thoracic vertebra (T2). A response-outcome contingency is established by applying shock to one hindleg whenever the leg falls below a preset criterion. Spinal neurons appear sensitive to this instrumental contingency, for subjects quickly learn to maintain their leg in a flexed position, effectively minimizing exposure to shock. Disrupting the response-outcome relation eliminates this learning. So too does the NMDA antagonist APV. Rats that have experienced the same amount of shock independent of leg position (noncontingent) fail to learn. Moreover, prior exposure to noncontingent shock undermines learning and/or performance when contingent shock is applied to the contralateral leg, a behavioral deficit that lasts at least 24 hrs. The experiments we propose examine the mechanisms that underlie instrumental learning within the spinal cord and its relation to other behavioral phenomenon. We propose to refine the methodology used to study instrumental learning. We will then explore the limits of learning, and whether the instrumental contingency affects the induction of central sensitization. Other experiments will further detail the nature of the behavioral deficit observed after noncontingent shock, whether supraspinal systems can inhibit its induction, how long the deficit lasts, whether it can be prevented or reversed, and the role of opioid peptides. Our studies speak to a broad range of topics, from the neurobiology of learning and memory to nociceptive plasticity and pain. Beyond these general concerns, an understanding of spinal cord plasticity, its limitations, how it is disrupted, and how it can be restored, may prove essential to the recovery of function after spinal cord injury.